Feedback and feedforward gating of sensory signaling through timing in the thalamocortical loop

Feedback and feedforward gating of sensory signaling through timing in the thalamocortical loop
Nearly all sensory experience begins in the periphery, generating sensory signals travelling through the thalamus
before reaching neocortex. Despite numerous anatomical and functional investigations into the feedforward
projections from thalamus to primary sensory cortex (TC), significantly less is known about the extensive
reciprocal corticothalamic (CT) feedback pathway that provides ~40% of input to the thalamus. One proposed
role of CT feedback is to control the salience of ascending sensory signals relative to background activity, thereby
regulating the selective detectability and discriminability of sensory stimuli, but this has not been explicitly tested
due to the complexity of the underlying circuit, the difficulty in disentangling loops of this nature, and the only
recent availability of tools designed to specifically target key elements of the circuit. This project will utilize a
range of tools to precisely measure and optogenetically manipulate elements of the TC-CT circuit in the whisker
somatosensory pathway of the awake head-fixed mouse during tactile perception, to develop the set of rules
by which cortical feedback gates signal processing in the thalamocortical circuit. First, the effect of L6CT
feedback projections on sensory signaling in the thalamus will be determined (Aim 1). L6CT neurons will be
optogenetically manipulated while recording extracellular population spiking activity in L6CT and across both
VPm and TRN, while delivering controlled sensory stimuli. Second, the effect of L6CT feedback on sensory
signaling in S1 cortex will be determined (Aim 2). In a range of targeted optogenetic manipulations, activity in
thalamus will be forced to desired baseline firing rates via a novel real-time closed-loop optogenetic control
framework, while recording across cortical laminae. Third, the bi-directional, corticothalamic control of the
salience of sensory evoked activity in the perception of sensory inputs will be assessed (Aim 3). Mice will be
trained in tactile tasks while monitoring population single unit activity across thalamus and cortex in the presence
of optogenetic manipulation of L6CT neuron activity. Significance. The feedforward thalamocortical circuit is
thought to play a dynamic and pivotal role in controlling perceptually relevant information flow, but corticothalamic
input to thalamus is extensive, providing an exquisite level of control of the signal processing of the pathway that
is very poorly understood. Success in this project could provide a significant advance in the understanding of
basic function in all sensory pathways, and provide a set of rules by which feedback acts to dynamically gate the
signal processing that is vital for navigating complex environments. Broader Impacts. Feedback loops play
critical roles in a range of neurological diseases and disorders, from the complex feedback loops involved in
Parkinson’s disease, to the excitability of circuits involved in certain forms of epilepsy, to the interaction between
brain structures in traumatic brain injury, and many others. Success in this project could therefore shed light on
a fundamental principle critical for shaping function in normal and disease states.

Public health relevance
Project Narrative Sensory input is critical in our daily lives, for both the perception of the world around us, and in providing feedback for our muscle systems that help us interact with the external world. How the nervous system dynamically performs this feat through feedback loops in brain circuits is unknown. Discovery in this area can potentially help us understand a number of disorders/diseases of the nervous system for which individuals exhibit loss of sensitivity, and do not have the ability to adapt to changes in the sensory environment.